Core Grant in Vision Research

PROJECT SUMMARY
The Vanderbilt Vision Research Center (VVRC) promotes transformative vision research, spanning the
eye and its diseases to visual cognition, memory, attention, and integration. We request continued support for
7 well-coordinated service modules coordinated through the administrative module to provide services and
capabilities that otherwise would be unavailable due to expense or need for specialized equipment, technical
infrastructure, or computational, informatic and data management resources. Animal Models, Histology and
Pathology, Instrumentation, and Computation and Data Management represent cores intrinsic to VVRC
facilities, while Sequencing and Informatics, Cell Imaging and Analysis, and Mass Spectrometry and
Proteomics subsidize use of the world-class institutional cores for which Vanderbilt is known. Animal Models
(1) provides essential services for use of nonhuman primates or other large mammals and supports animal
imaging capabilities through the Vanderbilt University Institute of Imaging Science. Histology and Pathology (2)
provides preparation, embedding, sectioning, and staining of all tissues derived from visual structures.
Instrumentation (3) provides customized apparatus and expertise in digital interfaces for equipment.
Computation and Data Management (4) provides server maintenance, programming for data analysis and
machine interfacing, system administration, and webpage-based applications and platforms for data
management. Sequencing and Informatics (5) subsidizes use of VANTAGE, or Vanderbilt Technologies for
Advanced Genomics for high-throughput DNA and RNA services, bioinformatic support, data analysis, and
biospecimen storage. Cell Imaging and Analysis (6) offers high-resolution confocal and laser-scanning
microscopy, electron microscopy, and other imaging modalities with high-performance image processing and
analysis through the Vanderbilt Cell Imaging Shared Resource (CISR). Mass Spectrometry and Proteomics (7)
supports use of the Mass Spectrometry Research Center (MSRC), which provides high-throughput analysis of
protein modifications, differential expression and spatial imaging, protein-protein interactions, and biomarkers
of disease. Finally, the administrative module ensures coordinated and stable operation of the VVRC research
and training missions. In the period since the beginning of the current grant cycle (7/2019 – 9/2023), our 52
members holding 18 active NEI R01 awards published 657 papers making made fundamental contributions to
basic and clinical visual science, with 414 from 41 faculty utilizing at least one service module and 201 utilizing
two or more. Each service module was utilized by no fewer than eight investigators, and 19 investigators
utilized at least three modules. This Core grant has increased collaborations within and between basic and
clinical vision researchers across the Vanderbilt campus and with other institutions. This Core grant has
enhanced recruitment of world-class vision scientists who continue extensive NEI-sponsored research at
Vanderbilt.

Public health relevance
NARRATIVE The long-term mission of the Vanderbilt Vision Research Center (VVRC) is to leverage novel technologies, strategies, and partnerships to (1) understand the biological substrates of vision and mechanisms of diseases affecting the visual system and (2) leverage this knowledge to inform, develop, and test new therapeutic strategies for vision-threatening conditions. Proposed service modules will support and enhance innovative and novel approaches spanning genes and proteins to brain circuits and behavior to better understand vision and ways to preserve it in aging and disease.